THE ROLE OF PARATHYROID HORMONE IN RENAL OSTEODYSTROPHY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. SPECIFIC AIMS: 1. To determine whether PTH concentrations measured by 2nd PTH-IMA provide a more accurate assessment of bone formation and turnover than PTH levels obtained with 1st PTH-IMA in and young adults undergoing chronic hemodialysis. 2. To determine whether PTH concentrations measured by 2nd PTH-IMA provide a more accurate assessment of bone formation and turnover than PTH levels obtained by 1st PTH-IMA in and young adults with chronic kidney disease (CKD) prior to dialysis. 3. To assess the magnitude and progression of renal and skeletal resistance to PTH and to determine whether the abundance of amino-terminally truncated PTH(1-84) fragments contribute to the state of resistance in young adults with CKD prior to dialysis, and of skeletal resistance alone in young adults undergoing chronic hemodialysis.